Patterning Genes in Retinal Development

Patterning Genes in Retinal Development
Project Summary
The long-range goal of this grant is to determine the cellular and molecular events that lead to the
generation of specific cell types in the vertebrate retina. In this renewal we focus upon endocrine signaling
pathways, nuclear hormone receptors, and genetic elements that regulate differential expression of the cone
visual pigment genes on tandemly-replicated gene arrays. In humans a tandemly-replicated array on the X
chromosome consists of one long wavelength-sensitive (LWS) gene followed by 1-9 medium wavelength-
sensitive (MWS) genes, which have diverged spectrally from LWS. This recent replication has provided most
humans with trichromatic color vision, because LWS, MWS, and SWS1 opsin proteins are uniquely expressed
in separate cone populations. Heritable defects in the LWS/MWS array result in various forms of color
blindness, X-linked retinal degenerations, and Bornholm Eye Disease, a cone dysfunction associated with high
myopia. Insights into regulation of differential expression of LWS vs. MWS opsins could allow therapeutic
manipulation of gene expression to treat these disorders. In addition, future regenerative approaches to the
treatment of other retinal disorders that involve the loss of cones (age-related macular degeneration;
Stargardt's disease) would ideally include similar in vitro or in vivo manipulations to generate cone phenotypes
in ratios that support high-acuity color vision. A decades-old model for human LWS vs. MWS opsin regulation
states that a stochastic event favors an association of an upstream regulatory region with the LWS or most
proximal MWS opsin promoter or exon. However, topographic patterns of the LWS:MWS ratio suggest that a
nonrandom, trans-regulatory mechanism may be involved. Pursuit of regulatory mechanisms has been limited
because within mammals, only primate and bat genomes are known to harbor tandem opsin arrays. In
contrast, the genomes of teleost fish, including zebrafish, contain numerous tandem arrays of opsins, which
are the consequences of independent gene replication events and neofunctionalization. In the previous award
period, we demonstrated that in zebrafish, the endocrine signal thyroid hormone (TH) regulates differential
expression of the tandem duplicates, lws1 vs. lws2, an array that shares a common ancestral LWS gene with
the genes of the human LWS/MWS array. Our preliminary data suggest the hypothesis that the TH receptor,
Thrb2 (already known to promote the LWS cone phenotype), may have been evolutionarily co-opted to also
regulate differential expression of lws1 vs. lws2, such that unliganded Thrb2 promotes lws2 and suppresses
lws1, while liganded Thrb2 promotes lws1. We have identified two predicted, palindromic TH response
elements (ppTREs) on the lws locus, and preliminary studies suggest that each element has roles in regulating
endogenous patterns of lws1 vs. lws2, and in the response to TH. Additional preliminary data suggest that TH
can regulate expression of LWS vs. MWS opsin transcripts in human iPSC-derived 3D retinal organoids.
Together these findings represent tremendous breakthroughs in revealing novel pathways for regulation of
tandemly-replicated gene arrays in vertebrates. In this renewal we drill down to examine the signaling
pathways, receptors, and genetic elements that mediate this regulation, with three Aims: Aim 1. Identify the
receptor(s) that mediate the response of lws1 and lws2 to TH. Aim 2. Identify the regulatory elements on the
lws locus that mediate the response of lws1 and lws2 to TH. Aim 3. Determine the role of TH signaling in
regulating LWS vs. MWS ratios in human cones.

Public health relevance
Patterning Genes in Retinal Development Public Health Impact Statement This project will discover mechanisms regulating the expression of “tandemly-replicated” cone visual pigment opsin genes, such as those on the human X chromosome encoding the red- and green-sensitive cone opsins. The results of the proposed studies will provide key information regarding endocrine signaling pathways, receptors, and genetic response elements that mediate this regulation. Understanding these regulatory pathways will be important as the Vision Science community develops regenerative medicine-based methods for replacing photoreceptors that are lost to disease or injury.